NARCH XII Admin-Core

Project Summary/Abstract:
The ANTHC NARCH XII Administrative Core is designed to ensure the success of the overall
ANTHC NARCH XII program and meet the needs of ANTHC. The overall goal of the ANTHC
NARCH XII program is to build on previous work by ANTHC NARCH and other programs,
existing strengths and partnerships, and identified needs to continue to increase the capacity of
Alaska Native people and tribal health organizations to conduct tribally-driven research in
pursuit of ANTHC’s vision that Alaska Native people are the healthiest people in the world. The
specific aims for the overall NARCH are to: 1) increase the capacity of Alaska Native people
and tribal health organizations to design and conduct health research while including indigenous
ways of knowing; 2) conduct tribally-driven health research focused on improving the health of
Alaska Native people and reducing health disparities; and 3) expand on existing ANTHC
partnerships. The ANTHC NARCH XII program consists of multiple components. Dr. Ferucci is
responsible for overseeing the center as PI, with the assistance of Co-Investigator Dr. Thomas.
The specific aims of the Administrative Core are to: 1) provide administrative, ethical, regulatory,
and fiscal guidance and oversight for each of the funded capacity building and research
projects; 2) oversee researcher and mentor development, with a focus on structured
mentor/mentee relationships and collaboration with existing career development and pilot grant
programs; 3) improve the research consultation and research review processes by ANTHC and
regional tribal health organization partners by supporting existing research consultation and
review committees with their capacity building and educational needs; and 4) support the
evaluation plans for each project and for the center as a whole. The Administrative Core will
enhance the ability of the overall ANTHC NARCH XII program to fulfill its specific aims,
including successful completion and evaluation of the capacity building and research projects.
The expected outcome is a continued improvement in ANTHC’s capacity to conduct tribally-
driven health research, ultimately leading to improved health, well-being, and resilience of the
Alaska Native population.